Identifying Predictors of Poor Health-Related Quality-of-life among Pediatric Hematopoietic Stem Cell Donors

ABSTRACT
This proposed longitudinal investigation builds on, and significantly extends, our preliminary work focused on
health-related quality-of-life (HRQoL) among sibling pediatric hematopoietic stem cell (HSC) donors.
Although the use of minors as HSC donors is medically and legally accepted, recent policy statements by the
American Academy of Pediatrics and our own preliminary work which found pediatric donor HRQoL deficits
indicate that additional research in this area is critical. Our preliminary work found that ~20% of healthy
pediatric donors experienced clinically important HRQoL deficits shortly before and up to one year following
donation. In addition, parents over-estimated HRQoL of the donor child and this overestimation was
particularly large for children with the poorest self-reported HRQoL. The overarching goal of this proposed
investigation is to identify predictors of poor HRQoL among some sibling pediatric HSC donors. In addition,
we will identify the most productive potential targets for, and content of, interventions or guideline changes to
improve HRQoL. The study will generate a new, large cohort of sibling pediatric donors, their recipients and
caregivers and three non-donor comparison groups. We will conduct interviews at pre-donation, and 4 weeks,
6 months and 1 year post-donation with 409 sibling pediatric HSC donors, their recipients and parents and
three key comparison groups – all nondonor siblings age 5-18 from the same family, nondonor siblings of
patients receiving unrelated transplants, and a matched sample of healthy comparisons. Medical data from
donors, recipients and transplant center data will be collected and merged with interview data. Analyses focus
on hypotheses derived from the existing literature, our own preliminary work, and a multivariable model to
determine which donor, recipient, family and center characteristics predict donor HRQoL. This investigation
is significant because (a) pediatric HSC donation is increasing, (b) it focuses on a vulnerable group of healthy
children being asked to undergo potential medical/psychological risk with no direct self-benefit, (c) it will
provide critical information about predictors of poor HRQoL among pediatric donors, (d) it will disentangle
whether observed HRQoL deficits are due to the donation process, to family dynamics, and/or to some other
aspect of having a critically ill sibling, and (e) it will provide the basis for guidelines/interventions to mitigate
the risk of poor donor HRQoL. The investigation is innovative because it will be the first to (a) examine
pediatric HSC donor HRQoL in a large nationwide sample, (b) provide important and novel comparisons with
nondonor children, (c) use an innovative application of group-based trajectory modeling to examine donor
HRQoL, (d) comprehensively evaluate the effects of donor/recipient/family/transplant factors on pediatric
donor HRQoL and (e) include a large ethnically diverse and Spanish-speaking sample. This investigation will
advance our understanding of HRQoL among sibling pediatric HSC donors and their families and provide
crucial information for the development of guidelines/interventions for this group.

Public health relevance
This project focuses on the physical, psychological, and emotional experiences of children who donate stem cells to an ill sibling. We will be collecting information by telephone interview from (a) 409 child donors (ages 5-18), (b) 326 nondonor siblings from the same families, and (c) their parents/caregivers before, four weeks after, 6 months after and one year after they donate. The telephone interviews will focus on how the child experiences the donation physically and psychologically, how it affects their relationship with their sibling, and how having a donor child and an ill child affect the family as a whole. Findings will (a) help us identify what factors are related to better or worse quality-of-life for the donor following donation, and (b) provide information that will help us design interventions to improve quality-of-life in donors and their families.